TH1 AND TH2 CYTOKINE STIMULATION OF MONONUCLEAR PHAGOCYTES IN ASTHMA

This study will characterize the inflammatory response of peripheral blood monocytes and alveolar macrophages from healthy subjects following stimulation with Th1 and Th2 cytokines.